Pediatric Eye Disease Investigator Group

Use continuation pages as needed to provide the required information in Start with Principal Investigator. List all other key personnel in alphabetical order, last name firsL Name Organization Roy W. Beck Jaeb Center for Health Rsch, Tampa, FL Danielle Chandler Jaeb Center for Health Rsch, Tampa, FL Jonathan M. Holmes Mayo Clinic, Rochester, MN Craig R. Kollman Jaeb Center for Health Rsch, Tampa, FL Raymond Kraker Jaeb Center for Health Rsch, Tampa, FL Pamela S. Moke Jaeb Center for Health Rsch, Tampa, FL Michael X. Repka Johns Hopkins University, Baltimore, MD the format shown below. Role on Project Principal Investigator Assistant Director Procedure Dev. & Op Ctr Sr. Biostatistician Assistant Director Dir., Systems Dev. Study Chairman Disclosure Permission Statement. Applicable to SBIR/STTR Only. See instructions. [] Yes [] No PHS 398 (Rev. 05/01) Page 2 Form Page 2 Principal Investigator/Program Director (Last, first, middle): Beck, Roy W. The name of the principal investigator/program director must be provided at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page .................................................................................................................................................. 1 Description,